Advancing Health Disparities Research in Aging: The Aging Research in Criminal Justice & Health (ARCH) Network

PROJECT SUMMARY / ABSTRACT
Despite 20 years of unprecedented growth in the number of criminal justice-involved older adults (those under
arrest, in court, in prison or jail, on probation or parole), the knowledge needed to develop evidence-based
interventions for this population with high rates of early onset disease, disability and behavioral and social risk
factors, is deeply under-developed. To address a dearth of research about this population, we launched the
Aging Research in Criminal Justice Health (ARCH) Network in 2019 to support multidisciplinary scholars
across all career stages to study the life course experiences of older adults involved in the criminal legal
system and the drivers of later life health disparities in this population. We now propose to renew the ARCH
Network to sustain and grow our early research success in studying key social determinants of health in this
rapidly growing population. The ARCH Network has enjoyed tremendous success, including developing a
superb group of early investigators and supporting established researchers to focus on this emerging area of
research. The ARCH Network draws on people with a tremendous diversity of background reflecting a wide
range of professional disciplines, including medicine, public health, nursing, criminology, law, psychology,
social work, and others. Since our launch, our scholars have published nearly 80 manuscripts in high impact
journals regarding the health of older adults in the criminal legal system, and have competed successfully for
extramural grant funding, including career development awards and R-series NIH awards. Many have been
recognized for outstanding scholarship at national conferences.
The Aims of our renewal application are to: 1) build upon the multidisciplinary research network we established
during the first ARCH network grant by creating specialized research cores including: Research Education;
Team Science; and Translation and Dissemination to advance research on the health and social drivers of
criminal legal system involvement and health disparities among older adults over the life course; and 2)
support new and established scientists to develop and conduct life course research on the health of older
adults in the criminal legal system through technical assistance and mentorship, pilot and exploratory research
funding, and opportunities for networking to develop new multidisciplinary research collaborations. The ARCH
Network will ensure that geriatric principles are front and center in studying the health and healthcare needs of
justice-involved older adults and will continue to refine and realize a research agenda that can inform carceral
and community healthcare systems about opportunities across the life course where programmatic and policy
interventions can be tested to reduce health disparities.

Public health relevance
PROJECT NARRATIVE The number of older adults involved in the criminal legal system (“justice-involved older adults”) has risen dramatically in recent decades, resulting in a growing population of older adults with profound, often co- occurring social and medical vulnerabilities and high rates of health disparities. We launched the ARCH (Aging Research in Criminal Justice Health) Network in 2019 a nationwide, multi-disciplinary community of emerging and established researchers, to catalyze research and interventions designed to improve health and social outcomes in the growing population of criminal justice-involved older adults. This proposal will further develop and sustain The ARCH Network to support emerging and established investigators to advance the conduct and dissemination of research on the health and social drivers of criminal legal system involvement and its consequences on health in later life and to accelerate the translation of this research into practice and policy that can care for this population.